Leadership, Planning and Evaluation

ABSTRACT – LEADERSHIP, PLANNING AND EVALUATION
As a NCI Comprehensive Cancer Center, Duke Cancer Institute’s Senior Leadership is the central decision-
making, institutional advisory body and is organized as a diverse and representative group that prioritizes and
promotes research productivity, investments, recruitment, endorses interaction and collaboration, takes
maximum advantage of institutional strengths, assures community involvement and fosters unique scientific
opportunities through a robust committee structure. These activities are delineated in the DCI overall and disease
specific strategic plans. The Executive Director actively seeks and fosters the opinions, feedback, guidance and
advice from Senior Leadership, who have expertise in operational and scientific leadership to plan and execute
priorities and initiatives.
Strong guidance, vision and advice is provided by a senior group of external counselors (External Scientific
Advisory Committee; Executives and Chairs from School of Medicine and Duke University Health System). All
counselors are an integrated part of DCI’s planning process. Strategic planning and evaluation have been critical
for the current systems reviews and future development of DCI. Ongoing planning, evaluation and guidance in
all areas, are a major responsibility for the committees discussed and are essential to maintaining a steep
scientific and operational excellence (performance driven, strategic and systematic processes) trajectory.
Rigorous planning and evaluation is carried out on an ongoing basis through multiple internal and external
mechanisms in all divisions of DCI.
The DCI’s Executive Director synchronizes and has broad authority across leadership, strategic planning,
clinical, evaluation, scientific, budgetary, outreach and administrative matters for the center. These priorities,
investments and initiatives are codified in the DCI strategic plan.